Improving adherence and outcomes in evidence-based treatment for OCD: Type I Effectiveness-Implementation RCT and Scaled Development of OC-Go, a crowdsourced interactive patient-provider tool

PROJECT SUMMARY/ABSTRACT
The long-term goals of this proposal are to improve treatment adherence and clinical outcomes in evidence-
based treatment (EBT) for obsessive compulsive disorder (OCD), a high base rate disorder and leading cause of
disability worldwide. Guidelines uniformly recommend exposure and response prevention (ERP) as the front-
line treatment. Meta-analyses consistently find large ERP effects, with about half of treatment completers
attaining complete remission. Yet, up to 40% of patients do not fully respond. Patient adherence to treatment
tasks between sessions, i.e., homework adherence, is by far the strongest predictor of treatment outcomes. Thus,
improving such adherence will likely produce greater OCD reductions. The literature indicates that a lack of real-
time support for patients between sessions and a lack of support for therapists after initial ERP trainings to learn
how to prioritize homework assignments in practice both contribute to poor ERP outcomes. Yet, standards to
support homework rely on pen-and-paper tracking methods, which have not changed in 40 years. Thus, new
solutions are needed to enhance adherence and improve clinical outcomes, in line with NIMH Strategic
Objectives 3.2, 3.3B, 4.2, and 4.3. OC-Go is a novel interactive digital health tool designed to improve ERP
adherence by leveraging the empirical predictors of adherence. The platform allows therapists to create and push
tailored multimedia behaviorally interactive assignments to patient mobile devices, providing step-by-step real-
time interactive guidance and homework support, facilitating a means for clinicians and experts to “appify”
behavioral health protocols without having to know how to code, and a means to share created activities to a
curated and searchable public library for other therapists to learn from and use. Thus, OC-Go facilitates
experiential support in practice for both patients and clinicians, leveraging mHealth, asynchronous telehealth,
and crowdsourcing for a new paradigm of high-fidelity CBT implementation. Early prototype testing in a small
RCT pilot demonstrated that OC-Go increased adherence by 22% and doubled the modeled treatment effect. The
platform also scored high on usability measures, however next-stage development of critical features is required
to support at scale crowdsourcing and commercialization. Phase I aims of this Fast-Track proposal are to develop
and test those required functions using a national sample of 105 ERP therapists to provide staged feedback for
agile development. Phase II aims are to: 1) test the effectiveness of OC-Go for improving homework adherence
and clinical outcomes, and 2) identify and address implementation barriers via a hybrid Type I effectiveness-
implementation RCT (N = 160 patients, 60 therapists) in the OCD & Anxiety Center (OAC) outpatient network.
The proposal is supported by NIMH recommendations for tools to improve EBT adherence and for peer-to-peer
learning tools in networks, a well-specified commercialization plan, OAC intention of contracting given positive
results, and interest from over 100 clinicians, dozens of mental health institutions, an exceptional assembly of
thought leaders and developers of 16 EBTs, and Oxford University Press, the leading publisher of EBT manuals.

Public health relevance
PROJECT NARRATIVE Exposure with response prevention (ERP) is the frontline treatment for obsessive compulsive disorder (OCD) often leading to remission, yet ~ 40% of patients do not fully respond. Limited between-session adherence to ERP assignments is the strongest predictor of poor treatment outcomes. This hybrid Type I effectiveness- implementation RCT will advance the field by developing and testing OC-Go, an innovative digital health tool designed to improve ERP adherence by facilitating key practice supports for both patients and clinicians in real time.